Redefining mesenchymal stem cells: using their cellular and molecular phenotypes to determine their regenerative and therapeutic properties

ABSTRACT
Mesenchymal stem cells (MSCs) have broad-based potential in regenerative medicine cell therapies and
can be isolated from a variety of different tissues. Though MSCs from different tissues are phenotypically
similar, a barrier to their clinical use is the high variability of their trophic and regenerative properties. This
variability suggests that inherent differences exist in the molecular machinery guiding MSC properties
between different MSC populations, yet, to date, these differences are ill-defined. To this end, we have
preliminary evidence that MSC phenotypes correlate to their regenerative outcomes. In this study, we aim
to elucidate how the molecular and cellular properties of distinct MSC populations determine their
regenerative properties. Our hypothesis is that MSCs from different tissues have different regenerative
properties which correlate to specific molecular profiles defined by gene expression and transcriptional
activity. To test this hypothesis, the project proposed has three Specific Aims (SAs). In SA1, we will
determine how tissue-specificity dictates gene expression and dynamic transcription factor activity
of distinct MSCs. SA2 will determine how differences in the cellular and molecular properties of
MSCs correlate to MSC phenotype. Finally, in SA3, we will determine how the molecular profiles and
cellular activities of MSCs dictate their regenerative properties. Findings of the proposed study will
provide novel insights about how the distinct molecular profiles of MSCs dictate their biological and
physiological properties. In a therapeutic context, this would enable the development of innovative
screening technologies for MSC therapies to identify and enrich for the most appropriate MSC for the
specific therapeutic application.

Public health relevance
PROPOSAL NARRATIVE Stem cell therapies are emerging as a new treatment approach to regenerate lost tissues, treat ischemic disorders, and treat chronic inflammatory conditions. Many of these approaches use stem cells from adults which are present in various regions throughout the body. Our research team is working to better understand how and why these adult stem cells behave the way they do so that we can better determine how to use them in different therapies to treat debilitating health conditions.